Dissecting the molecular mechanism of the cardiac fight-or-flight response via real-time light-controlled phosphorylation of Rad

Abstract:
The fight-or-flight response is a critical regulator of heart function and major target of cardiovascular therapeutics
for heart failure, arrhythmias, and ischemic heart disease. In response to stress, catecholamines released by
the sympathetic nervous system stimulate β-adrenergic receptors on cardiomyocytes, resulting in increased
heart rate and contractility. Although existing medications targeting upstream components of this pathway are
effective therapeutics for cardiovascular disease, they often cause undesirable non-cardiac side effects. Rad,
a small RGK-family GTPase and calcium channel inhibitor protein, has emerged as a downstream mediator of
β-adrenergic signaling and a promising target for cardiac-specific therapeutics. In response to β-adrenergic
stimulation, Rad is phosphorylated by protein kinase A (PKA), resulting in disinhibition of Cav1.2 and an
increase in the L-type calcium current responsible for excitation-contraction coupling. However, the molecular
mechanism by which Rad phosphorylation results in Cav1.2 current enhancement remains poorly understood.
The objective of this proposal is to elucidate the physiological significance of Rad phosphorylation in regulating
Cav1.2 function in the cardiac fight-or-flight response to inform the development of novel cardiac-specific
therapeutics. To do this, we propose an innovative approach combining chemical biology and electrophysiology
to achieve precise temporal and spatial control of Rad phosphorylation. By encoding the unnatural amino acid
caged-serine, a derivative of serine that is “decaged” to natural serine by a brief pulse of near-UV light, at
phosphorylation sites S273 and S301, we will achieve real-time, site-specific, light-mediated control of Rad
phosphorylation during electrophysiological recordings of Cav1.2 currents. In Aim 1, we will employ a
heterologous cell culture system to quantify the distinct contributions of S273 and S301 phosphorylation to
Cav1.2 current enhancement upon forskolin-induced PKA activation. In Aim 2, we extend these studies to ex
vivo cardiomyocytes isolated from Rad-knockout mice, enabling us to examine Rad phosphorylation in the
context of native cardiac β-adrenergic signaling pathways.
By elucidating the molecular mechanisms of Rad-mediated Cav1.2 regulation, this study will offer critical
insights into the cardiac β-adrenergic response. These findings will lay the foundation for developing next-
generation, cardiac-specific therapies targeting Rad phosphorylation for the treatment of cardiovascular
diseases. The successful completion of this work will provide comprehensive training in biomedical research
techniques, supporting the fellowship applicant's long-term goal of achieving a career as a physician-scientist
dedicated to advancing the understanding and treatment of cardiovascular disorders.

Public health relevance
Project Narrative: Medications targeting upstream factors in the cardiac fight-or-flight response are vital for treating heart failure, arrhythmias, and ischemic heart disease, but their lack of cardiac specificity often leads to undesirable side effects. This research aims to uncover how phosphorylation of Rad, a key downstream regulator of this response in the heart, controls calcium channel function. By identifying novel pathways for cardiac-specific drug development, this study has the potential to improve treatments for cardiovascular disease and enhance public health outcomes.